Intersectional Stigma, Mental Health, and HIV Risk Among US Gay and Bisexual Men of Color

PROJECT SUMMARY/ABSTRACT
The burden of HIV is far from equally distributed in the US. Key metrics of the HIV epidemic continue to be
predicted by demographic factors (e.g., race, gender, sexual orientation, geography). At the intersection of
these determinants is one of the highest-risk groups for HIV infection in the world, and this project's
population of interest: Black and Latino gay, bisexual, and other men who have sex with men (GBM) in the
US South. Such individuals endure multiple forms of stigma (e.g., racism, homophobia), which elevate stress
and erode health. Thus, applying theories of intersectionality and minority stress to epidemiological and
intervention research may provide novel insights and tools to support the health of this vulnerable subgroup.
The proposed training plan will provide Skyler Jackson, PhD, with the essential knowledge and skills
necessary to develop independence and forge a career advancing scientific knowledge concerning
intersectional stigma as a determinant of mental and sexual health risk among Black and Latino GBM. The
goals of this mentored award are summarized by three distinct training objectives: (1) to gain skills using
contemporary epidemiological methods, (2) to learn best practices in qualitative, community-engaged
intervention development, and (3) to develop foundational skills in clinical trials methodology. Dr. Jackson will
put these aims into practice via three novel, interrelated research projects, in which he will: (1) use
longitudinal data from a prospective cohort study to identify mediators and moderators of the association
between intersectional stigma and mental/sexual health among GBM of color across distinct US geographies,
(2) combine these findings with data from formative research (e.g., 30 interviews with GBM of color and
community stakeholders in Middle Tennessee) to modify an existing evidence-based stigma-coping health
intervention for GBM—using the 8-phase ADAPT-ITT model—thereby increasing its cultural and geographic
relevance to the mental and sexual health of Southern Black and Latino GBM, and (3) pilot this intersectional,
culturally-responsive health intervention for young Southern Black and Latino GBM (n = 30; across two
sequential cohorts) in collaboration with a community partner in Middle Tennessee. To develop his
independence as a scientist, Dr. Jackson will be mentored by John Pachankis, PhD (Yale University), with
support from additional co-mentors: Lisa Bowleg, PhD (George Washington University), Dustin Duncan, ScD
(New York University), and Mark Hatzenbuehler, PhD (Columbia University). Where knowledge gaps remain,
Dr. Jackson will engage in carefully selected training activities—e.g., grant writing, coursework, conferences,
and manuscript preparation. Much of this training will be made possible by institutional support available
through Dr. Jackson's joint affiliation with the Yale Center for Interdisciplinary Research on AIDS, Yale School
of Public Health (YSPH), and YSPH Esteem Research Lab in New York City. Dr. Jackson's K01 training plan is
optimized to address his training gaps and prepare him for a productive career as an independent scientist.

Public health relevance
PROJECT NARRATIVE Black and Latino gay, bisexual, and other men who have sex with men (GBM) residing in specific regions of the US (for example, the South) represent one of the most at-risk populations for acquiring HIV in the world. The NIMH has identified research priorities in their effort to address this enduring health inequity, including: (a) the application of intersectional research methods to study how various forms of stigma—such as racism and homophobia—jointly contribute to this health disparity through specific mediators and moderators, and (b) using this knowledge to develop targeted culturally-responsive intersectional interventions to help prevent HIV transmission among Black and Latino GBM in high-risk contexts. By clarifying whether, where, and through which mechanisms intersectional stigma serves as a fundamental driver of mental health and HIV risk—and adapting a treatment to target the mediators and moderators of these syndemic, co-occurring stigma-health effects—this project aligns with these NIMH priorities, fills a significant gap in the scientific literature, and informs intervention efforts to support the health and resilience of Southern Black and Latino GBM.